Effect of Pulsed Splenic Ultrasound on delaying Chronic Kidney Disease Progression through a Neuroimmune Mechanism.

PROJECT SUMMARY
Chronic Kidney Disease (CKD), a progressive condition that affects over 10% of the population, has emerged
as one of the leading causes of mortality worldwide. Episodes of acute kidney injury (AKI) may predispose
patients to progression to CKD. Although pharmaceutical agents are continually being developed for CKD, most
have only limited efficacy and there are considerable side effects. Furthermore, there are few therapies that can
reduce post-injury fibrosis after established AKI. There is a continuing need to develop novel and innovative
strategies for the prevention of AKI and importantly, the subsequent transition to CKD. Pulsed ultrasound (pUS),
a non-pharmacological noninvasive technology, has substantial potential to meet this need. There has been a
growing body of literature demonstrating the ability of ultrasound energy to modulate cells and activate neural
circuits. Furthermore, preclinical studies have utilized ultrasound to target immune cells within the spleen to
reduce inflammation in both acute and chronic models. Controlling inflammation by neuroimmune modulation
may lead to new therapeutic modalities for CKD that are effective after established injury.
Prior studies from our lab demonstrated a protective effect of non-targeted ultrasound in preventing ischemic
AKI and that this was dependent upon the cholinergic anti-inflammatory pathway (CAP). Preliminary data
presented here demonstrates that pUS targeted to the spleen reduces inflammation and protects against toxin
induced AKI. Our hypothesis is that therapeutic US can be applied after injury to reduce fibrosis and delay the
progression of CKD through activation of the CAP. In Aim 1, I will optimize a pUS regimen to delay the
progression of CKD and determine whether there is a therapeutic window of intervention. In Aim 2, I will take a
mechanistic approach to understand the effect of ultrasound on the CAP. Specifically, I will determine whether
the protective effect of US is due to activating the splenic nerve or due to a direct effect on splenocytes.
Furthermore, I will characterize the phenotypic changes in immune cells of the spleen and kidneys after pUS.
This proposal involves scientific, professional, and clinical training. Research will be carried out under the
guidance of kidney disease expert, Dr. Mark Okusa, ultrasound experts including Dr. John Hossack and Dr.
Jonathan Lindner, and immunology expert, Dr. Timothy Bullock, at the University of Virginia. This research will
involve additional collaborations and guidance from investigators in the fields of neuroscience and immunology.
In addition to providing a potential impactful clinical solution for CKD, this proposal offers a significant training
opportunity. Throughout the course of the fellowship, I will have the opportunity to 1) acquire skills in multiple
experimental techniques 2) develop a strong knowledge base in kidney disease research 3) receive expert
training and guidance in an emerging novel technology 4) learn to communicate my findings to a variety of
audiences and 5) foster connections with the nephrology clinical community.

Public health relevance
PROJECT NARRATIVE The ability of pulsed ultrasound (pUS) to noninvasively modulate the immune system offers an unprecedented opportunity to improve outcomes in chronic inflammatory diseases such as chronic kidney disease (CKD). We have used pUS as a pretreatment to provide protection in preclinical models of acute kidney injury. In this work, we propose to leverage the immunomodulatory effects of pUS to develop a novel therapy for CKD with a goal towards laying the groundwork for future clinical trials.